Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The Administrative Core represents the executive, coordinating and oversight component of the Joint Biology
Consortium (JBC). The Brigham and Women’s Hospital, Boston Children’s Hospital, and collaborators have
much to offer researchers in arthritis and related diseases, but smooth access to these resources requires a
shared logistical infrastructure. The Admin Core develops and maintains this infrastructure, keeping JBC
members informed of the latest technological advances and maximizing opportunities for collaborative studies.
Importantly, the Admin Core will leverage the expertise and commitment of JBC members to develop the next
generation of top-flight musculoskeletal researchers. This work is reflected in two aims.
First, an experienced team of investigators and administrators will ensure efficient, fiscally-responsible
operation of the JBC Resource Cores to provide key tools for arthritis research, coordinated through a central
user interface: the JBC Web Portal. This team will monitor service utilization, user feedback, and research
productivity. Leadership will work together with the JBC Advisory Committee to adapt the JBC rapidly to
member needs to ensure optimal utilization of JBC resources.
Second, the JBC will build the arthritis research community through the monthly JBC Synergy Meeting,
communication through the JBC Web Portal and an electronic newsletter, the JBC visiting professor program,
and outreach. Importantly, the JBC Enrichment Program will foster junior investigators through the Aims
Review Committee, the JBC Mentoring Program, and the JBC Microgrant Program, including dedicated
programmatic attention to diversity and inclusion to ensure optimization of the JBC researcher pool.
The Admin Core is led by committed arthritis researchers and award-winning mentors Dr. Peter Nigrovic and
Dr. Elizabeth Karlson, supported by a skilled administrative team, a JBC Executive Committee composed of all
core service leaders, and oversight through the JBC Advisory Committee chaired by Dr. Michael Brenner.
Together, this team will ensure that the JBC becomes an even more effective community of junior and senior
investigators working toward the common goal of understanding inflammatory arthritis.